Training Program in Cardiac Innovation

Summary
Cardiovascular disease in the American population is continuously a major source of debilitation and death
despite increased prevention, diagnostic, and treatment options. This calls for increased scientific understanding
and innovative application of these findings to the care of patients to prevent or cure heart disease. This training
program in cardiovascular innovation is designed to teach the scientific and technical skills necessary to develop
a novel idea and carry this idea through to proof-of-concept in humans. The training program takes unique
advantage of the strengths of the Lillehei Heart Institute, the University of Minnesota Cardiovascular Division,
the wider community of translational medicine and entrepreneurship at the University of Minnesota, and the Twin
Cities biotech, pharma, and device industries. This application will train basic and clinical scientists in an
interdisciplinary environment to give them the insight and tools to be able to successfully carry an idea from
conception to implementation in humans. Therefore, the goal of this Training Program is to provide an
interdisciplinary research and training environment wherein trainees will be exposed to the continuum of
technological development from conceptual idea to testing at the basic, small animal, large animal, and human
levels. Trainees will be advantaged by community strengths in basic, translational, and clinical science, training
in cardiovascular innovation and entrepreneurship, and industry interactions and mentorship. There are several
unique features of this training program: 1) the focus on cardiovascular sciences, 2) the scientific qualification of
its Trainers, 3) the curriculum focused on innovation, 4) the presence of industry mentors, and 5) the opportunity
for meaningful industry interactions. The program will consist of a basic cardiovascular curriculum augmented
by specific training in cardiovascular innovation. Each trainee has the opportunity to participate in the Bakken
Innovation Fellows Program. The goal of this program is to train the next leaders in MedTech by fostering
leadership and teaching risk management for medical innovations. Trainees will also partake of the Carlson
School of Management Medical Industry Leadership Institute (MILI) program offerings. MILI offers students
innovative experiences through industry-specific courses and unique, hands-on evaluations of emerging
technologies from around the globe. Trainees will take at least 2 relevant half-day courses offered by the
Technological Leadership Institute: 1) Innovation, Leadership & Communication, 2) How to Create and Stimulate
a Culture of Innovation, 3) Communication in a Technical Environment: Developing Writing and Presenting Skills,
and 4) the yearly Innovation Workshop "Becoming a Medical Technology Innovator." Trainees will engage in a
minimum of 3 years of research training. The first two years of training will be for innovation and other didactics
and for carrying out the research. Year 3 will be dedicated predominantly to developing a business plan related
to the project and writing an appropriate grant application for career advancement. For PhDs, this would consist
of a K99/R00 award application, and for MD trainees, the application would be for the K08 or K23 programs.

Public health relevance
Project Narrative The major goal of this Training Program is to provide an interdisciplinary research and training environment wherein trainees will be exposed to the continuum of technological development from conceptual idea to testing at the basic, small animal, large animal, and human levels. Trainees will be advantaged by community strengths in basic, translational, and clinical science, training in cardiovascular innovation and entrepreneurship, and industry interactions and mentorship.